Anti-medin immunotherapy for vascular aging and related dementias

ABSTRACT
Age is the most important risk factor for cardio-cerebrovascular diseases (CVD) and dementia disorders.
Epidemiologic, preclinical and clinical data show that vascular disease is strongly associated with dementia
disorders, including Alzheimer's disease (AD) and AD-related dementias (ADRD) such as vascular dementia
(VaD). Indeed, unbiased data-driven analyses showed that vascular dysfunction is the earliest and strongest
brain pathology associated with late onset AD. There is growing evidence that medin, a 50-amino acid peptide
that forms one of the most common yet least studied human amyloidoses, is an important driver of vascular
aging pathologies. We and others showed that vascular medin burden was associated with VaD, AD and aortic
aneurysms. Medin, a cleavage product of milk fat globule-EGF factor 8 protein (MFGE8), accumulates in vessels
with aging, causes endothelial dysfunction through oxidative and nitrative stress and induces endothelial pro-
inflammatory activation that could initiate neuroinflammation. Knockout of MFGE8 domain containing medin
prevented cerebrovascular medin amyloid formation and restored cerebrovascular function. We designed and
produced an immunogen modified from the aggregation-prone C terminus of medin to be used as anti-medin
vaccine and 3 monoclonal antibodies (mAbs) that have high medin affinity. Our overall goal is to evaluate anti-
medin immunotherapy using medin vaccination (Aim 1) and anti-medin mAbs (Aim 2) to attenuate or prevent
medin-induced vascular dysfunction and neurovascular pathology in aging C57BL/6 mice and in senescence
accelerated mouse-prone 8 (SAMP8) mice. Aim 1 is to develop and test the benefit of anti-medin vaccination in
preventing cerebrovascular and cognitive dysfunction and neurovascular pathology in C57BL/6 aged and
SAMP8 mice. We will first determine an optimal vaccination regimen and then test the efficacy of that regimen.
Aim 2 is to develop and pilot test anti-medin mAb immunotherapy to attenuate medin-induced cerebrovascular
and cognitive dysfunction and neurovascular pathology in C57BL/6 aged and SAMP8 mice. First, we will
determine which mAb (19H1, 6F2 and 13B7) will have the best effect in reversing medin-induced endothelial
cytotoxicity. Next, we will do pilot feasibility in vivo testing of the ideal dosing of anti-medin mAbs to reduce
cerebrovascular medin and preserve cerebrovascular and cognitive function. The proposal is innovative and
paradigm-changing in potentially establishing medin as a new target for vascular disease and dementia, and
anti-medin immunotherapy as a potential new treatment approach for vascular aging and resulting pathologies.

Public health relevance
PROJECT NARRATIVE Dementia disorders are associated with and caused in part by aging-related vascular disease. Medin is a protein that accumulates in blood vessels with aging and is implicated in dementia disorders. Our goal is to develop and test vaccination against medin in 2 mouse models as well as monoclonal antibody against medin in order to prevent the vascular and neuropathologic impairment caused by medin. If successful, this could lead to new ways to prevent or treat vascular aging and dementia.